Community Ambulation Following Hip Fracture

DESCRIPTION (provided by applicant): The ability to ambulate in the community is of critical importance for carrying out daily activities; yet 50% of hip fracture patients who walked independently before a fracture require assistance to walk 10 feet a year later, and many of those that are able to walk without assistance move so slowly that they are no longer able to walk a distance considered adequate for community ambulation. The proposed study will evaluate the ability of a high intensity, 16-week, multi-component exercise program beginning two months post-fracture to improve patients' ability to walk a community ambulation distance at 4 months post-initiation of the program. Forty exercise sessions will be provided in patients' place of residence under the direct supervision of physical therapists; exercises will be targeted to improve endurance, balance, muscle strength, and functional task performance. This two group randomized clinical trial will determine if a 16-week training program can improve patients' ability to walk a community ambulation distance of 300 meters in six minutes at 4 months following randomization. Three clinical sites (University of Maryland Baltimore; Arcadia University; University of Connecticut Health Center) will recruit a total of 300 community dwelling hip fracture patients (aged 65+) following hospitalization, and randomly assign them to a 16-week high intensity, supervised, home delivered multi-component exercise program or a control intervention consisting of stretching and range of motion exercises, and low level transcutaneous electrical stimulation. Patients will be randomized after standard post- acute rehabilitative care ends (2 months post-fracture). Patients in both groups will receive supplemental vitamin D3, calcium, a multivitamin and nutritional counseling to promote weight stability and adequate nutrient intake. The primary endpoint is the ability to walk 300 meters in 6 minutes four months post randomization. Other endpoints include precursors (i.e., endurance, balance, muscle performance, and lower extremity function) and selected underlying mechanisms (i.e., intra-muscular fat, quadriceps volume, circulating inflammatory cytokines, and VO2 peak) to community ambulation. Cost effectiveness also will be evaluated. The study is designed to detect at least a 20 percentage point difference between the exercise and control groups in the primary outcome with 90 percent power (alpha=. 05) in an intention to treat analysis. Results will lead to a better understanding of the dynamics of innovative post hip fracture physical therapy. Implications of study findings will relate directly to hip fracture patients' ability to ambulate independently in the community and the cost-effectiveness of the proposed intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: More than 325,000 hip fractures occur annually in the US, with associated health care costs estimated at $14-20 billion. The goal of current clinical practice is independent, safe household ambulation, at 2-3 months post surgery, yet hip fracture-acquired dependency persists well beyond three months. This study will evaluate a 16-week multi-component exercise program provided to patients in their homes to determine if it is effective in improving the ability to walk independently in the community (i.e., community ambulation). RELEVANCE: More than 325,000 hip fractures occur annually in the US, with associated health care costs estimated at $14-20 billion. The goal of current clinical practice is independent, safe household ambulation, at 2-3 months post surgery, yet hip fracture-acquired dependency persists well beyond three months. This study will evaluate a 16-week multi-component exercise program provided to patients in their homes to determine if it is effective in improving the ability to walk independently in the community (i.e., community ambulation). __SpecificAimsTextDelimiter__ Despite improvements in medical management, significant residual disability remains in older persons after a hip fracture.8-10 The goal of current clinical practice is independent, safe household ambulation at 2-3 months post surgery.11 Hip fracture-acquired dependency in functional activities of daily living persists well beyond three months post-surgery. One year after hip fracture, 20% of patients need help putting on pants, 50% need assistance to walk, and 90% need assistance to climb stairs.9 This residual disability indicates that current standard Medicare-reimbursed post-hip fracture rehabilitation (i.e., usual care) fails to return many patients to pre-fracture levels of function. In contrast to stroke and heart disease, other commonly occurring acute conditions in the older population, there are a limited number of intervention trials focused on decreasing disability following hip fracture. None of the trials for hip fracture have examined the effect of early post fracture intervention on the ability to ambulate at a level required for independent function in the community (i.e., community ambulation). Thus, there is a paucity of evidence to justify extending medical management beyond usual care in persons post fracture to achieve community, rather than merely household, ambulation. The proposed randomized clinical trial (RCT) will evaluate a 16-week, supervised multi-component intervention that is introduced as soon as the patient completes usual care (typically within two-three months of the fracture). The intervention relies on specificity of training and overload principles, and will be provided in their place of residence (i.e., home delivered). The goal is to enable hip fracture patients to recover sufficiently to become community ambulators. In addition, the effect of the intervention on four precursors for community ambulation will be examined, as will the economic merits of delivering this intervention. Effects on selected underlying mechanisms on the pathway to recovery will be examined in a subgroup of enrolled patients. A total of 300 patients will be enrolled, 100 in each of three (3) sites. (1) Primary Aim. To determine if a multi-modal 16-week intervention based on aerobic conditioning, specificity of training, and muscle overload initiated 2-3 months post fracture is more successful in producing community ambulators at 4 months after study entry (approx. 6 months post fracture) than a control intervention of transcutaneous electrical nerve stimulation (TENS), flexibility activities, and active range of motion exercises. Primary Hypothesis: There will be a 20 percentage point or greater difference in the proportion of experimental compared to control patients who achieve a community ambulation distance threshold following the intervention. Community ambulation threshold is defined as walking at least 300 meters in six minutes (on the Six Minute Walk Test (SMWT)), a measure indicative of the ability to ambulate in the community. (2)Secondary Aims. a. Persistence of effect. To determine if the difference between the experimental and control groups in the proportion of persons who achieve a community ambulation distance threshold at 4 months persists to 10 months post randomization (approx. 12 months post fracture). b. Effect on precursors for community ambulation. The experimental intervention is focused on modifying four precursors to community ambulation: endurance, dynamic balance, lower extremity muscle performance, and lower extremity function. To gain a better understanding of the effect that the intervention has on each of these precursors, treatment and control groups will be compared at 4 and 10 months post-randomization on measures of endurance, dynamic balance, lower extremity muscle performance, and lower extremity function using the absolute 6 Minute Walk Distance, Berg Balance Scale, dynamometry for quadriceps strength, and Modified Physical Performance Test, respectively. c. Cost-effectiveness of multi-component intervention. The economic value of the intervention will be determined by assessing its impact on quality-adjusted life years (QALYs), cost, and cost per QALY gained over the 10 months following initiation of the intervention. This RCT will provide critical information on whether a multi-component intervention that targets key deficits underlying community ambulatory ability can improve a hip fracture patient's ability to ambulate in the community in a cost-effective manner. (3) Tertiary Aim (Mechanistic sub-study aim). Effects on underlying mechanisms. Selected factors presumed to be on the pathway to improved recovery in physical function will be examined (in a subgroup of 100 patients in one clinical site). We will determine if patients in the experimental intervention group have lower percentage of intra-muscular fat, greater volume of the quadriceps (both measured by CT scan), lower levels of circulating inflammatory cytokines, and higher VO2 peak, at 4 months post randomization than those in the control group.